Tele-Sox: A Tele-Medicine solution based on wearables and gamification to prevent Venous thromboembolism in Oncology Geriatric Patients

PROJECT SUMMARY/ABSTRACT
Venous thromboembolism (VTE) is a leading cause of preventable hospital death in the US resulting in greater
than 100,000 deaths annually. Advanced age, surgery, cancer, immobilization, and hospitalization are common
causes of VTE. Overall, 20% of all VTE cases occurs in patients who have cancer. VTE was also a significant
predictor of mortality during the first year of diagnosis in patients with all types of cancer. Not only the risk of VTE
is high in the hospitalized patients because of long immobility, its risk remains elevated up to 3 months after
discharge. VTE is also highly prevalent among COVID-19 patients even after the hospital discharge.
Current methods of prophylaxis for VTE have significant limitations. For instance, the use of pharmacologic
prophylaxis is mostly limited to the inpatient setting, due to increased rates of bleeding complications. Current
non-pharmacological interventions are inefficient due to lack of compliance, impracticality for in-home care, cost,
and supervision requirements especially in elderly population.
To address the limitations described above STEXOLE LLC is partnered with Baylor College of Medicine (BCM)
to design and commercialize an innovative tele-medicine-based smart sock named Tele-SOX. This device
includes three major components: 1) Sensor-Exergame: a patented interactive game- based foot and ankle
exercise program based on a wearable sensor, which will be integrated into the sock and enables delivering
personalized game-based lower extremity exercise, ensuring improving venous return and prevention of VTE;
2) a series of adjustable weights add-on to socks to personalized resistive exercise; 3) tele- medicine: a
mobile application installable on a tablet or a smart phone enables interaction with care providers as well as
guiding patients to execute effective and personalized exercise tasks and gamification features to engage
patient and remind him/her for recommended dosage of needed exergame per day.
The scientific premise of the proposed platform relies on our initial study demonstrating effectiveness of the
proposed exergame program on increasing venous blood flow volume on average by 49% after just 3-minute
interactive and virtually supervised repetitive foot and ankle exercise, while reducing hospital acquired weakness.
During Phase I, the initial platform will be improved to make it suitable for home-based use and non-tech savvy
users (Aim 1). In addition, the proof of concept of the platform will be assessed in a convenient sample of 15
geriatric oncology inpatients (age 50+) to demonstrate its feasibility and proof of concept efficacy to improve
venous-return flow in response to 3-5 min usage of the device (Aim 2). Finally, by interviewing recruited
participants and 15 clinical experts unaffiliated with the project, we will assess perception of benefit and ease of
use. After successful achievement of the milestones of the Phase I, During Phase II, the gaming interface will
be further developed (more games, inter-connectivity of patients), and will be tested for its effectiveness to reduce
risk of VTE, improve mobility, reduce readmission risk, and enhancing the quality of life.

Public health relevance
PROJECT NARRATIVES A significant proportion of geriatric oncology patients are at high risk of developing life-threatening venous thromboembolism (VTE). Current intervention methods, especially among older adults, are inefficient due to lack of compliance, impracticality for in-home care, cost, and supervision requirements. We are developing a smart sock, which enables interactive, practical, game-based foot and ankle exercise with tele-medicine feature that is tailored to improve venous return flow essential to prevent VTE as well as accelerate functional recovery post hospital discharge.